Core B: Animal Core

PROJECT SUMMARY/ABSTRACT – CORE B: Animal Models Use and Development Core
In this competing renewal P01 application, Core B (Animal Model Core) will support the development and use
of the animal models utilized within this Program Project Grant. The guiding principles for the animal model core
are efficient planning and utilization of animals, standardization of processing and diagnoses, reliability of service
and consistent evaluation of animal models. The fundamental expertise provided within the core is laboratory
animal medicine and clinical and anatomic pathology. The specific aims of Core B are:
a. Collaboration with Project 1: The antibody response as well as T cell responses of HLA-A2 restricted
epitopes will be tested after vaccination with mRNA vaccines in HLA-transgenic mice. The
immunogenicity and protective ability of mRNA vaccines will be evaluated in rabbits against infection,
and protection against proliferative disease in humanized mice transgenic for HLA-A2.
b. Collaboration with Project 2: HTLV-1 infected T cell lines (HTLV+T) will be inoculated into NCG/hIL2
mice with subsequent analysis of HTLV+T by flow cytometry and RNA sequencing. HTLV+T or their
extracellular vesicles (sEV) will also be introduced, and their effects on the bone microenvironment
assessed morphologically and with single cell RNA sequencing approaches. sEV effects will also be
tested with antagonists to sEV-derived miRNAs, and in mice lacking serum amyloid As (SAAs).
c. Collaboration with Project 3: Rabbits and HIS mice will be infected with HTLV with mutations in the
viral enhancer element (vEnhancer) and vCTCF-BS to study persistent infection or disease development,
respectively. NSG mice will be implanted with ATLL cell lines with or without deletion of the vCTCF-BS
in order to study its influence on DNA looping and tumor development as well as epigenomic regulation
of HTLV reactivation.

Public health relevance
PROJECT NARRATIVE – CORE B The overall theme of the PPG is to analyze how viral elements lead to latency and reactivation of HTLV-1, how the tumor cells interact with their bone microenvironment and to develop an mRNA HTLV-1 vaccine. After acute infection, HTLV-1 persists in the organism, eventually leading to oligoclonal and finally monoclonal proliferation and transformation of CD4 T cells. The virus uses CTCF binding site for infection, establishment and reactivation of viral latency (project 3; Ratner). These leukemic cells spread throughout the organism and cause osteolysis (project 2; Veis). A mRNA vaccine against Hbz may be able to provide protection against infection (project 1; Green/Panfil). Core B supports the program project grant through the rabbit model, mouse xenograft models and mouse model with a human immune system (HIS mice). In these animal models, all of the above named problems can be addressed.